Training in Mechanisms and Clinical Presentation of Pain

The overarching goal of this training program is to train the next generation of pain researchers. We will
continue to train both pre- (two per year) and post-doctoral (two per year) fellows in the fundamental principles
of pain, as nociceptive signals arise and are modulated throughout the body and ultimately integrated in the
brain to produce the sensory and emotional experience. We will continue to build on the training program
developed through the first two funding periods of this grant around a combination of more formal coursework
and less formal training experiences designed to provide not only a solid background in pain mechanisms and
management, and a greater appreciation of the burden of pain, but in a variety of skills critical for career
development including the use of cutting edge and rigorous and statistically sound methodology, literacy in
quantitative approaches to pain research, networking, and oral and written communication. We are committed
to an integrated approach to the study of pain which is based on our belief that major breakthroughs in this
field can only be achieved through multidisciplinary approaches. This is most clearly manifest in practice
through interactions between [1] laboratories (horizontal integration) and [2] researchers and clinicians (vertical
integration). Accordingly, horizontal and vertical integration are essential components of this training program,
which consists of three core elements: 1) Research - Multidisciplinary research projects are not only
encouraged, but expected, as is exposure to clinical management of pain/pain-related problems. Horizontal
and vertical integration will be achieved both through the choice of project, shaped by a primary mentor with
input from the executive committee, and through the formation of multidisciplinary mentoring committees which
will include at least one clinical faculty member among a three to four-member committee. 2) Theory - Trainees
participate in four required for-credit courses: Mechanisms and Clinical Presentation of Pain, Pain Journal
Club, bi-weekly Current Research on Pain presentations, and Pain Models – Rationale, Testing and
Interpretation, as well as the monthly Pain Seminar Series, where trainees interact with prominent pain
researchers. These courses serve as a primary venue to address issues of scientific rigor, proper use of
statistics in experimental design and analysis, quantitative literacy, as well as reinforce issues associated with
the responsible conduct of research. 3) Practice - Trainees will be exposed to the assessment, diagnosis and
treatment of chronic pain patients through three primary venues: 1) the Mechanisms of Clinical Presentation of
Pain course includes a series of lectures directed at assessment diagnosis and treatment of specific
subpopulations/aspects of pain patients (visceral, headache, geriatric, etc); 2) One-on-one interactions with a
clinician as a member of the training committee, that is often associated with opportunities for trainees to
shadow pain physicians as they interview, diagnose and manage pain patients; and 3) Participation in activities
organized by the Challenges in Managing and Preventing Pain (CHAMPP) Clinical Pain Research Center that
involves exposure to clinical pain research, pain clinicians, and pain patients.

Public health relevance
Pain is the principal reason for seeking medical attention, respects no boundaries, is not restricted to any one disease or medical discipline, is distributed across the life span, and experienced by all irrespective of status (economic, educational, etc.) age or gender, and remains difficult to manage if it can be managed at all. Novel and more effective treatments for pain that are so desperately needed will only be discovered by the hard work of the next generation of pain scientists. Thus, this training program fills a compelling need by enhancing and broadening the training of the next generation of pain researchers.